Transcriptional-translational conflict in bladder epithelial homeostasis and cancer

ABSTRACT
Chromatin remodeling and protein synthesis are tightly regulated processes that impact gene expression and
cellular phenotypes. However, it is unknown to what extent these two regulatory mechanisms may be linked or
independent in controlling normal epithelial physiology and disease states. We have uncovered a new functional
relationship between the chromatin remodeler ARID1A and mRNA translation elongation. This link is involved in
maintaining cellular fitness in the context of bladder carcinogenesis and represents a new tumor suppressive
mechanism we call transcriptional-translational conflict. Loss of ARID1A triggers a simultaneous increase in
oncogenic transcripts, but also inhibition of the translation elongation factor eEF2, which results in a reduction in
protein synthesis and prevents cancer pathogenesis. However, this process can be reversed by restoring
translation elongation, which enables the efficient synthesis of oncogenic mRNAs and cancer progression. This
finding provides a unified gene expression model which explains why ARID1A is a context specific tumor
suppressor. Importantly, ARID1A deficient tumors retain a sensitivity to pharmacologic inhibition of translation
elongation initiation. Recently, our laboratory has developed and characterized new in vitro and in vivo models
of both human and murine ARID1A deficient bladder cancer where we can also toggle translation elongation.
We have used these models to discover a critical link between ARID1A and the process of mRNA translation
elongation that is vital for urothelial homeostasis and bladder cancer progression. We hypothesize that
transcriptional-translational conflict in urothelium lacking ARID1A is mediated through decreased eukaryotic
elongation factor 2 (eEF2) activity, which when reversed unleashes a poised druggable oncogenic program
sufficient to drive cancer progression. Our long-term objective is to utilize state-of-the-art mouse models and
primary organoid systems, whole transcriptome polysome profiling, and patient derived xenografts to definitively
investigate the fundamental link between ARID1A and protein synthesis regulation in a highly relevant population
of bladder cancer patients. To do so, we will address the following aims: 1) Determine the relevance and
mechanism of transcriptional-translational conflict in urothelial cell transformation and carcinogenesis; and 2)
Elucidate how gene expression parity enables cancer progression and represents a context specific therapeutic
vulnerability. This research will help us gain a deeper understanding of the biology of bladder cancer and open
a new paradigm for treating patients with lethal disease. Our work is particularly important for the progress of
precision medicine because it seeks to mechanistically tie a highly prevalent bladder cancer genotype (ARID1A
loss) to a new treatment modality that holds therapeutic promise for bladder cancer patients.

Public health relevance
PROJECT NARRATIVE We have uncovered a new functional link between the ARID1A chromatin remodeler and the process of mRNA translation elongation important for urothelial cell maintenance and cancer pathogenesis. This discovery is clinically significant, as ARID1A-deficient cancers are exquisitely sensitive to inhibition of translation elongation initiation. Our goal is to definitively investigate the functional link between chromatin remodeling and protein synthesis control, as well as determine the therapeutic implications of targeting this interface.